CEGS: Center for Synthetic Regulatory Genomics - Renewal

Title: Center for Synthetic Regulatory Genomics
Abstract
The Center for Synthetic Regulatory Genomics (SyRGe) is tasked with development and
application of revolutionary technology for making dramatic, coordinated changes to
extensive gene loci in the form of Big DNAs of 50-1000 kb, which enable broad
investigation of the function of regulatory sequences and foster translational applications
to biotechnology, personalized medicine and aggressively humanized mouse models.
Specifically, we will (i) enhance our Design – Build – Deliver Technology pipeline ot
make it ever more efficient and precise, ii) enable “Bottom up” fully synthetic regulatory
landscapes, as well as multilocus engineering in both cells and animals, culminating in
projects to look at brain function and behavior iii) deploy combinatorial genomics at the
level of Big DNA, iv) Develop new tools to engineer megabase changes to mammalian
genomes in a locus-agnostic manner and v) Develop imaging technology to “light up” the
Big DNA molecules we are delivering.
The Center will dramatically supersede present and predicted technologies for
manipulation and assessment of Big DNAs. Some of this work will culminate in the
production of extensively humanized animal models called Genomically Rewritten and
Tailored Genetically Engineered Mouse Models (GREAT-GEMMs), an element of our
program worthy of bioethical debate and discussion. The Center also features a unique
and highly successful outreach program whereby undergraduates from diverse
backgrounds play a crucial role in genome assembly, as well as a Fellows program to
expose researchers and students from other fields to transformative new technology and
facilitate its promulgation throughout the larger human genetics, model organism and
genomics communities. Finally, mechanisms to ensure long-term sustainable access to
the technology developed in this Center to anyone who wishes to deploy it have been
put in place.

Public health relevance
Project Narrative In the first years of its existence this Center for Synthetic Regulatory Genomics has generated about 40 “Big DNA” molecules, most of which are more than 50,000 base pairs long and many of which are 100,000-200,000 long, as well as the technology to deliver these DNAs to stem cells, and ultimately to make mouse models. These resources have been used to dissect how genes are turned on and off in real human or mouse chromosomes and have also produced powerful models of human disease.